Borrelia burgdorferi mitogen in development of arthritis

DESCRIPTION (provided by applicant): Lyme Disease is caused by infection with the tick-borne spirochete Borrelia burgdorferi, and results in arthritis in up to 60% of infected individual. Arthritis is characterized by edema, inflammatory cell infiltration, synovial hyperplasia, and reactive/reparative changes in joint tissue, with the knee frequently involved. Most individuals respond to antibiotic therapy, eventually resolving symptoms of arthritis. Lyme arthritis been studied in mice, with severe disease reproducibly seen in C3H mice at 4 wks of infection, and mild to moderate disease found in C57BL/6 (B6) mice. Interestingly, arthritis in C3H mice is independent of effectors of the adaptive immune response. This is in contrast to numerous reports in patients identifying T cell responses in synovial fluids of arthritic joints. Interestinly, infection of B6 mice lacking IL-10 (B6 IL10-/-) have revealed a central role for CD4+ T cells in disease development, suggesting this mouse to be a useful model for study of arthritis-associated T cell responses in Lyme disease. Arthritis in B6 IL-10-/- mice is characterized by elevated production of cytokines (IFNγ, IL-6 and IL1β) and chemokines (CXCL9 and CXCL10), which have also been identified in the synovial fluid of patients with chronic Lyme arthritis. The localized inflammatory response is sustained in IL-10-/- mice for at least 14 wks, when levels of B. burgdorferi are no longer detected. Arthritis development in the IL-10-/- mouse is dependent on localized production of IFNγ by infiltrating NK cells and CD4+T cells, while mild arthritis in B mice reflects local production of IL-10 by CD4+ T cells and macrophages. We propose that the comparison of B6 and IL-10-/- mice will allow assessment of protective and disease potentiating T cell responses in early and chronic Lyme disease, which has not been previously exploited. In Aim 1 we will assess functional properties of antigen-specific and bystander-activated T cells from B. burgdorferi-infected IL-10-/- and B6 mice. Cytokine production, TCR Vβ usage, and dependence on TLR2 will be assessed, and bystander vs. antigen specific responses tested with TCR transgenic mice. In Aim 2 we will pursue a new direction for the Lyme disease field, the potential involvement of the NF-κB dependent microRNA, miR-146a, in the regulation of the inflammatory response to B. burgdorferi. miR-146a provides feedback of NF-κB responses by targeting key components of the signaling pathway, and is upregulated in B. burgdorferi infected mice. Previous studies with MyD88 and TLR2 deficient mice failed to reveal a role for NF-κB-dependent responses in arthritis development, however, host defense was severely compromised. Our preliminary studies suggest the miR-146a-/- mouse may provide an excellent opportunity to assess the pro-arthritic arm of NF-κB responses in the absence of its normal feedback.

Public health relevance
Narrative: Lyme Disease is caused by the tick borne spirochete Borrelia burgdorferi, and is the most common vector borne disease in the United States. Inflammatory dysregulation is a key feature of Lyme Disease in both the severe, subacute disease and in more chronic inflammatory disease. This application proposes to characterize the nature of the T cell response to B. burgdorferi and the involvement of microRNAs in regulation of disease development, using mouse models of Lyme Disease.